Regulation of SNARE-mediated autophagosome-lysosome fusion by accessory proteins

PROJECT SUMMARY:
The efficient management of sub-cellular injury, protein misfolding and organelle damage through the process
of autophagy is critical for maintaining cell health and preventing the development of disease including
neurodegeneration and cancer. One of the first steps in autophagy involves sequestering sub-cellular material
within a vesicular structure called an autophagosome. Autophagosomes are then brought into proximity with
lysosomes, the degrative organelle of the cell, to enable trans-SNARE assembly and subsequent merger of the
two compartments; this delivers the autophagosome-encapsulated material to the acidic and proteolytic
environment of the lysosomal lumen for degradation. Without efficient autophagosome-lysosome (Auto-Lyso)
fusion, sub-cellular material accumulates, severely impacting cellular health and function. It is critical to elucidate
how Auto-Lyso fusion is regulated to understand the molecular determinants of autophagy-associated disease.
Primary objectives of my lab are to describe how a SNARE-binding protein, sec1-family domain containing
protein 1 (SCFD1), and a Ca2+ sensor, synaptotagmin 7 (SYT7) regulate Auto-Lyso fusion. SCFD1 was recently
reported to be a regulator of Auto-Lyso fusion. Interestingly, mutations or aberrant expression of SCFD1 has also
recently been implicated in the development of neurodegenerative disease. This project will characterize SCFD1
function at the molecular level and describe the mechanisms that underlie how dysregulation of SCFD1 leads to
disease. The second main project outlined in this proposal examines the Ca2+ regulation of Auto-Lyso fusion
through the action of a lysosome-resident Ca2+-binding protein, SYT7. It has been shown that cancer cells
upregulate both SYT7 expression and autophagy to facilitate proliferation, but a connection between SYT7 and
autophagy has not been reported. The lysosomal lumen is enriched in Ca2+ and it has been demonstrated that
Ca2+ is released from the lysosome during autophagy. Although Ca2+ is a tightly regulated and ubiquitous trigger
of myriad membrane fusion reactions, a bone fide Ca2+ sensing protein for Auto-Lyso fusion has not been
established. We hypothesize that SYT7 is activated by Ca2+ release from the lysosome to trigger Auto-Lyso
fusion.
Our lab will address these basic questions through a combination of in vitro biochemistry and advanced
fluorescence imaging of mammalian cells to describe how Auto-Lyso fusion is regulated at the molecular level.
Of importance, part of our in vitro biochemical approach includes a unique single-molecule technique with
microsecond time resolution, known as nanodisc-black lipid membrane electrophysiology. This proposal marks
the first use of this technique in the context of autophagy. Together, this work will provide novel insights into the
regulation of Auto-Lyso fusion and describe the detailed molecular mechanisms that implicate both SCFD1 and
SYT7 in the development of autophagy-associated disorders.

Public health relevance
NARRATIVE: The efficient degradation of proteins and lipids, through the process of autophagy, is critical for maintaining cellular homeostasis and preventing the development of disease. This project combines in vitro biochemistry and advanced fluorescence imaging of mammalian cells to describe the molecular mechanisms that regulate one of the critical final steps in autophagy: the SNARE-mediated fusion of a vesicular structure called the autophagosome with the degrative organelle of the cell, the lysosome. By elucidating how autophagosome- lysosome fusion is regulated at the molecular level, and characterizing human mutations that are known to disrupt this fusion reaction, this work will provide new insights and approaches that can be applied to the treatment or prevention of disease progression caused by aberrant autophagy.